Synthesis of Environmentally Relevant Nanoplastics and their Toxicological Consequences Mediated by Environmental Pollutants and Biomolecule Adsorption

Project Summary / Abstract
Plastic waste is a global environmental and health concern. Degradation of plastics results in the generation of
micro- and nanoplastics which are currently ubiquitous within the environment and have diverse properties in
terms of composition, shape, size, and inclusion of manufacturing additives. Humans are exposed to micro- and
nanoplastics through numerous routes of exposure including oral, inhalation, and dermal via their presence
within water, foods, and air. Measurable amounts of plastic particulates have been found in human volunteers in
various tissues and safety evaluations of representative nanoplastics utilizing cell culture and animal models
have demonstrated the potential for toxicity. The consequential biological and adverse health effects associated
with these emerging nanoplastic exposures are not well understood. Currently, most toxicity assessments
evaluating nanoplastics utilize pristine representative polystyrene nanoparticles which may not represent
environmental exposure scenarios and the biological mechanisms induced following exposures. To address this
significant limitation, we have developed a novel procedure to reproducibly generate micro- and nanoplastics of
increased environmental relevance from common plastic waste materials. Our assessment supports these
plastic particles have appropriate physicochemical properties (composition, size, shape, charge) and induce
differential in vitro toxicity including cytotoxicity, inflammation, and oxidative stress. This procedure for generating
nanoplastics is innovative and allows for the investigation of fundamental and translatable mechanisms of
toxicity. Specifically, evidence suggests nanoplastics can adsorb hazardous environmental contaminants on their
surface enhancing their toxicity. This adsorption is likely governed by properties of the nanoplastic and the
environmental contaminant. Further, following entry into the body particulates associate biomolecules which may
facilitate unique cellular interactions and toxicity. Our ability to produce environmentally relevant nanoplastics
with differing physicochemical properties allows for the evaluation these nanoplastic-environmental contaminant
and biomolecule interactions which may govern subsequent toxicological consequences. Our preliminary data
support physicochemical modifications influence environmental contaminant and biomolecule association
influencing cellular interactions and responses. This proposal examines the hypothesis that environmentally
relevant nanoplastics will induce toxicity dependent on physicochemical variations (composition and size) via
modulation of environmental contaminant and biological interactions. The hypothesis will be tested through
completion of two main goals: 1) Quantification of nanoplastic interactions with common environmental
contaminants and the toxicological consequences; and 2) Determination of nanoplastic-biomolecule interactions
modifying cellular responses. These interactions represent key initial regulators and mechanisms governing
subsequent cell recognition and toxicity. Completion of the project will generate new knowledge of environmental
significance necessary for the understanding of nanoplastic human health effects.

Public health relevance
Project Narrative Nanoplastics generated from plastic waste are a significant emerging exposure concern due to their environmental abundance and undetermined toxicity. This proposal utilizes a novel approach to generate nanoplastics of environmental relevance to investigate physicochemical driven interactions with prevalent environmental contaminants and biomolecules resulting in toxicological consequences. Elucidation of these initial mechanisms related to nanoplastic hazards are necessary for environmentally and human relevant investigation of nanoplastic risks and the understanding of their contribution to exposure-induced diseases.